Nanomaterials to improve growth factor delivery to the cornea

This proposal describes a 3-year mentored career development plan to foster a transition to research
independence in the fields of ocular biomaterials and drug delivery. The candidate, Levi N. Kanu, M.D., is an
Instructor in Ophthalmology at Harvard Medical School, an Investigator at Schepens Eye Research Institute,
and a practicing cornea specialist at Mass Eye and Ear. The proposed career development plan will be
conducted in the enriching environments of the Harvard community, including Schepens Eye Research
Institute, Mass Eye and Ear, and the Harvard School of Engineering. His background includes scientific training
in chemical engineering, medical devices, drug delivery, cell culture, animal models, and clinical and surgical
management of ocular diseases. His long-term goals are to become a thought leader in his area of research
and to make important advances in the treatment options for patients with ocular diseases. This proposal
outlines a comprehensive plan to achieve scientific independence through 1) systematically investigating
novel techniques for ocular protein delivery, 2) refining grantsmanship skills, 3) developing leadership and
managerial skills, and 4) fostering early career collaborations. Dr. Kanu’s proposal includes regular educational
seminars, structured coursework, regular meetings with expert mentors, and clearly defined milestones. The
advisory committee will include the following: 1) Primary Mentor Dr. Joseph Ciolino, an expert in ocular drug
delivery; 2) Co-mentor Dr. Reza Dana, a scientific leader in corneal disease with extensive clinician-scientist
mentorship experience; 3) Collaborator Dr. David Mooney, a renowned expert in biomaterials and drug
delivery; and 4) Collaborator Dr. Dimitrios Karamichos, an expert in corneal biology and wound healing.
The proposed basic and translational research plan will be conducted primarily at Schepens Eye Research
Institute and aims to address the challenges associated with therapeutic protein delivery to the cornea.
Specifically, Dr. Kanu will study the feasibility of a novel nanocomposite hydrogel to achieve sustained and
localized nerve growth factor-delivery to the ocular surface as a treatment for diabetic keratopathy, since
effective treatments for this condition are currently lacking. Dr. Kanu will perform the following investigations: 1)
study the effects of physicochemical nanoparticle properties on nerve growth factor-release kinetics and
epithelial cell interactions of a nanocomposite hydrogel; 2) study the effect of continuous nerve growth factor
exposure on corneal epithelial cell receptor activation and consequent cell functions; and 3) study the effects of
continuous nerve growth factor exposure on diabetic corneal epithelium and nerves using in vitro and in vivo
models of diabetic keratopathy. The proposed research may lead to improved methods to efficiently deliver
proteins to the ocular surface. Both the proposed technology and the systematic approaches may be adapted
to other large molecule therapies. Finally, findings from this research may provide scientific evidence to support
a clinical trial and will form the basis of an R01 application by the end of the K08 award period.

Public health relevance
PROJECT NARRATIVE Protein growth factors are integral to effective corneal wound healing, and numerous proteins have shown promise as therapeutic agents; however, practical challenges associated with topical protein-based therapies limit or prevent their clinical use. The proposed research aims to improve our methods of protein delivery to the ocular surface through the development of a sustained drug-release, nanocomposite hydrogel. This novel biomaterial will be developed using nerve growth factor as a model protein therapeutic, tested on in vitro and in vivo models of diabetic keratopathy, and will result in a drug delivery system poised to be translated into clinical applications.